Enhancing Autophagy and Mitochondrial Biogenesis to Mitigate Cardiac Reperfusion Injury

PROJECT SUMMARY: In reperfused myocardial infarction (MI), approximately 50% of cell death is due to
reperfusion injury, which still lacks clinical therapies. There is an urgent need to fill in this knowledge gap and to
develop novel therapies for this. Initial appropriate mitochondrial quality control is critical for cardioprotection
following ischemia/reperfusion (I/R). Mitochondrial homeostasis is tightly regulated by two processes: mitophagy
(degradation of damaged mitochondria by autophagy) and mitochondrial biogenesis. Autophagy, an
evolutionarily conserved process required for cellular constituent recycling (including mitochondria), is impaired
during I/R. Mitochondrial biogenesis is regulated in part by peroxisome proliferator-activated receptor gamma
coactivator-1 alpha (PGC1). Importantly, mitochondria biogenesis is not increased by I/R injury in the kidney
and brain, despite induction of PGC1. These results suggest that impaired autophagy/mitophagy
following I/R contributes to the attenuation of mitochondrial biogenesis. Enhancing autophagy and
mitochondrial biogenesis simultaneously during I/R may therefore restore mitochondrial homeostasis.
Consistent with this, our unpublished data show that specific induction of autophagy with Tat-Beclin peptide at
the time of reperfusion reduces infarct size in mice, and augments PGC1 expression and mitochondrial
biogenesis (dependent on the autophagy). Similarly, pharmacological activation of autophagy at the time of
reperfusion (using the FDA-approved HDAC inhibitor, SAHA) induces autophagy and PGC1 and reduces
infarct size >40%. Moreover, SAHA plus PGC1 overexpression further increased mitochondrial biogenesis.
Studies in the brain have identified Parkin and PARIS as the regulator of PGC1 expression. To study
Parkinson’s disease, mouse models, and small molecules enhancing Parkin activity are available.
Hypothesis: Activation of autophagy confers cardioprotection during I/R through the combined removal of
damaged mitochondria and subsequent replacement via PGC1-dependent mitochondrial biogenesis, in a
Parkin-PARIS dependent manner, and enhancing both processes will afford more effective cardioprotection.
Aim 1. To determine whether autophagy is both necessary and sufficient for mitochondrial biogenesis
under basal conditions and during cardiac I/R.
Aim 2. To define whether autophagy-mediated mitochondrial biogenesis and cardioprotection during I/R
are dependent on the Parkin-PARIS-PGC1 signaling axis.
Aim 3. To establish whether simultaneous enhancement of autophagy/mitophagy and mitochondrial
biogenesis during cardiac I/R will augment cardioprotection.
Significance and novelty. This study will determine whether autophagy and PGC1-dependent mitochondrial
biogenesis is critical for reperfusion injury. Clinically, inducing autophagy and mitochondrial biogenesis during
the reperfusion is pharmaceutically feasible, which may lead to novel therapies for reperfusion injury.
1

Public health relevance
PROJECT NARRATIVE: In cardiac ischemia/reperfusion (I/R) injury, approximately 50% of cell death is due to reperfusion injury, for which there are no standard clinical therapies. This proposal will study the importance of two biological processes using specific FDA approved medicines to induce autophagy and PGC1-mediated mitochondrial biogenesis during reperfusion injury. This study may lead to a new therapy for heart attack patients that results in less heart damage and a better quality of life for these patients.